Develop manganese-containing porous scaffolds with vasculature-like channels for potential applications in craniofacial bone regeneration

Project Summary
As bone substitutes for autografts and allografts, synthetic porous scaffolds have limitations in the repair
of critical-sized craniofacial bone defects due to insufficient vascularization and bone formation. To
address these issues, in this project we propose to construct a new vasculature-like channels internal
structure and add manganese dioxide (MnO2) hollow nanoparticles in a porous beta-tricalcium phosphate
(b-TCP) scaffold to facilitate new blood vessel growth and stimulate osteogenesis. This strategy
harnesses the new mimicking vasculature-like channels to stimulate cell recruitment and promote the
invasion of new blood vessels, and utilizes the new inorganic Mn-containing nanoparticles to promote
osteogenesis. Specifically, a template-casting technique combining 3D printing will be employed to
develop vasculature-like channeled porous MnO2/b-TCP scaffolds. The concentrations of MnO2
nanoparticles in the b-TCP, the optimal channel size of the vasculature-like channels, and the in vivo cell
infiltration, tissue biocompatibility, and vascularization of the new scaffold will be fully investigated. To
achieve this goal, we will pursue the following three specific aims. Aim 1: Investigate the effect of MnO2
nanoparticles on the mechanical, physicochemical, and biological properties of porous b-TCP scaffolds.
Aim 2: Investigate the effect of 3D channels on the mechanical, physicochemical, and biological
properties of porous MnO2/b-TCP scaffolds. Aim 3: Examine the tissue biocompatibility, pro-angiogenic,
cell-instructive functions of the channeled scaffold in a mouse subcutaneous model. After we complete
this three-years proposed project, we will generate a new scaffold with mimicking structures and
osteogenesis-stimulating components for craniofacial bone tissue regeneration. This proposed project
will be the foundation for our long-term goal to translate this synthetic porous scaffold for the regeneration
of large craniofacial bone defects.

Public health relevance
Project Narrative The repair of craniofacial bone defect is still a challenge due to the complex anatomic shape and limited regenerative ability of synthetic scaffolds. The goal of this study is to develop a vasculature-like channeled scaffolds containing inorganic nanoparticles for the management of craniofacial bone defects. The new proposed scaffold will bring a potential for enhancing vascularization and bone formation.